NIDA Supplement for R13 entitled "Enhancing Dissemination and Career Development via the APA AnnualConvention"

Project Summary This administrative supplement request is to request funding from NIDA for seven travel awards for early stage investigators to attend the 2019 annual convention of the American Psychological Association (APA), and to highlight their research in a special poster session and networking event. This event, called the “Early Stage Investigator Poster Session and Social Hour,” has been taking place at the annual convention of the APA for the past twelve years, and has been co-sponsored by APA Divisions 50 and 28, made possible through funding from NIAAA and NIDA. Funding from NIAAA has been formalized for the past 12 years through an R13 award, for which I have been serving as PI for the past 2 years. Funding from NIDA for this event has taken several forms over the years, including a recent R13, which is ending in January 2019. We have recently submitted a stand-alone R13 to NIDA to request funding for the APA convention years 2020- 2022. To bridge the currently anticipated gap year for the 2019 convention in terms of NIDA's participation in this joint event, we are submitting this administrative supplement request.

Public health relevance
Project Narrative This project contributes to public health by supporting early career substance use researchers in the context of the American Psychological Association's annual convention. The project will support the pipeline of new researchers developing careers in substance use research. In addition, the activities in this application will promote greater awareness of new findings within the scientific community and to the broader community of psychologists.